SpinSeq

Project Summary
RNA sequencing technologies are crucial for understanding gene expression, regulation, and the role of RNA
modifications in health and disease. These technologies allow researchers to explore how genes are turned on
and off as well as how RNA modifications influence cellular processes, contributing to a wide range of biological
functions and disease mechanisms. Traditional RNA sequencing technologies often require the conversion of
RNA into complementary DNA (cDNA) before sequencing, which results in the loss of critical RNA modifications.
Without accurate detection of RNA modifications, our understanding of the regulatory mechanisms that control
RNA and protein production—vital for cellular function and adaptation to environmental changes—suffers
significantly. Alternatively, direct RNA sequencing platforms, such as those relying on motor-driven nanopore
technologies, offer the potential to sequence RNA molecules without converting them to cDNA, thus preserving
the modifications. However, these methods suffer from high error rates, making it difficult to accurately detect
and quantify RNA modifications, while the complex secondary structures of RNA molecules further complicate
the sequencing process, often resulting in incomplete or inaccurate data. New and advanced RNA sequencing
technologies are urgently needed to overcome these challenges, enabling precise modification detection and
full transcriptome analysis. This Phase I SBIR project aims to develop SpinSeq, an innovative platform designed
to deliver highly precise and accurate RNA sequencing, setting a new standard for transcriptomic analysis.
During this Phase I project, we will develop and refine a unique, tailored RNA sequencing technology, focusing
on maintaining RNA integrity and ensuring precise sequencing. The project will focus on developing and
optimizing the SpinSeq platform’s functionality, demonstrating its capability to be multiplexed for eventual high-
throughput sequencing applications, and testing its performance on various RNA samples with and without our
target modifications, e.g., N6-methyladenosine (m6A), 5-methylcytosine (m5C), and pseudouridine (Ψ), which are
crucial for understanding gene expression regulation and disease mechanisms. The PI's career development
and mentoring plans are integral to the success of this project. The PI will receive guidance from seasoned
researchers, participate in the NIH I-Corps program to enhance entrepreneurial skills, and receive training in
cutting-edge sequencing technologies. Additionally, the PI will actively engage in scientific conferences and
workshops to build a professional network and gain insights from experts in the field. These efforts will not only
enhance the PI’s technical and entrepreneurial expertise but will also ensure the successful commercialization
of the SpinSeq platform. Ultimately, this project aims to establish SpinSeq as a groundbreaking tool for RNA
research by addressing the limitations of existing technologies and delivering a more accurate, reliable, and
scalable solution for both transcriptomic and epitranscriptomic studies.

Public health relevance
Project Narrative This project will develop SpinSeq, a groundbreaking RNA sequencing technology designed to significantly enhance the accuracy and efficiency of RNA analysis, directly addressing critical needs across all areas of RNA research. By enabling precise detection and characterization of RNA modifications, SpinSeq has the potential to drive advancements in a wide range of fields, from basic biological research to drug discovery and personalized medicine. Commercially, SpinSeq is poised to capture a significant share of the rapidly expanding RNA sequencing market, estimated to reach $3.8 billion by 2027, by offering a superior alternative to current technologies and opening up new possibilities for scientific exploration and innovation.